Core B: Research Translation Core

The Research Translation Core (RTC) is the main modality by which information of value and relevance to assessing issues related to environmental health and dealing with brownfields and Superfund site characterization, remediation and/or utilization becomes available to the broad range of stakeholders. It has developed a very effective management structure, which involves a State Agencies Liaison (SAL) to ensure that there is excellent communication with our state partners and other regulatory agencies (EPA as well as regional regulatory groups). This program has made an operational decision to define as the scope of the activities covered by the RTC as communications on a professional-to-professional level, because there exists a closely coupled, but separate, Community Outreach Core (COC) that has as a main focus communication with non-professional stakeholders (the community). This definition of responsibilities ensures coverage of all key stakeholders, while establishing reasonable scopes for the RTC and COC. The Specific Aims of the Research Translation Core may be summarized as follows: Specific Aim 1. Provide an effective communication interface between the SBRP and governmental agencies (especially our state partner agencies) and other SBRPs. Specific Aim 2. Offer local health, regulatory, business, educational, journalistic, and economic organizations access to the best current scientific understanding of relevant environmental issues, and coordinate with the COC in these activities. Specific Aim 3. Provide Brown SBRP investigators mechanisms by which their results find both the broadest and most appropriate scientific audiences. Specific Aim 4. Offer technology transfer and development mechanisms within the program.

Public health relevance
The over-arching goal of this Superfund Basic Research Program is to address health concerns, and to design novel remediation techniques, related to mixed exposures arising from contaminated lands and buildings, using Rhode Island as a model for appropriate research, educational, and training interventions.